EPIDEMIOLOGY ON THE INTERNET

DESCRIPTION: (Adapted from Investigator's Abstract) The investigators propose assistance of more than 750 experts from 74 different countries. Quality control procedures such as those developed in industry will be used to monitor quality of the lectures. The library of lectures will be provided free to epidemiology instructors worldwide to rapidly "teach the teachers" and disseminate information to the students. The utilization of mirrored sites will permit easy and rapid access to most areas of the world. The primary goals of this project are to: 1) develop a 200 module lecture library that is continually monitored for quality through statistical quality control methods and 2) assess optimal approaches for Internet translation of information.